Inhalation exposure assessment to microplastics for workers in the laundry and dry cleaning industry

Abstract
Although exposure to microplastics and nanoplasctis (hereafter, microplastics) in general populations has been
widely assessed, workers’ exposures to microplastics at workplaces are mainly unknown. Limited laboratory
studies estimated that workers are exposed to airborne microplastics several orders of magnitude higher than
general populations. Moreover, inhaled microplastics were found in all parts of the lung in humans and found
significantly higher levels in the lower lung. Thus, workers handling or manufacturing materials containing
microplastics are at increased risk for adverse health effects (e.g., respiratory outcomes) from microplastic
exposures at their workplaces. To our knowledge, no studies have directly examined personal exposure to
microplastics among workers, especially in the Service Sectors. Textiles made from synthetic (plastic) fibers are
significant sources of occupational exposure to microplastics. Although workers in the drying cleaning and
laundry industry are exposed to synthetic fibers (containing microplastics) by handling clothing and linens daily,
these workers’ exposure to microplastics is largely unknown. Further, review studies summarized that workers
in the garment industry handling synthetic fibers (including nylon, polyester, acrylic) had a higher prevalence of
respiratory diseases than non-exposed populations. Hence, workers in the drying cleaning and laundry industry
experience may experience a large burden of exposure to microplastics at their workplaces. In 2021, the dry
cleaning and laundry industry in the United States employed 160,000 -244,000 persons, excluding self-employed
persons. This industry is expected to grow nationally from $10.8 billion in 2020 to $14.4 billion by 2025. However,
the impact of exposure to emerging microplastics on workers in this business sector is unknown due to the lack
of exposure assessment. This proposed R21 study, in response to the National Occupational Research Agenda:
the Services Sector and the Cross-sector of Healthy Work Design, will evaluate the effects of key determinants
(work hazards, characteristics of workplace and workforce) on inhalation exposure to microplastics in the laundry
and dry cleaning industry. We aim to (1) measure inhalation exposure to microplastics from 30 workers in the
laundry and dry cleaning industry, and (2) determine the effects of work-related factors (workforce, workplace,
and work hazards) on inhalation exposure to microplastics among these workers. The results will inform a future
intervention study and training program to develop strategies for reducing workers’ exposure to microplastics in
the Service Sector. The proposed research will also improve a scientific knowledge gap by informing workers’
exposure to microplastics that can be deposited in the human lungs, and by examining the association between
microplastic exposure and adverse health effects among workers in the Services Sector.

Public health relevance
Narrative Although workers in the drying cleaning and laundry industry are exposed to synthetic fibers (containing microplastics) by handling clothing and linens every day, these workers’ exposure to microplastics is mainly unknown. Further, the effects of work-related factors (workforce, workplace, and work hazards) on exposure to microplastics among these workers are not investigated. This proposed R21 study, in response to the National Occupational Research Agenda: the Services Sector and the Cross-sector of Healthy Work Design, will provide helpful information for workers, industry, local, state, and national agencies, and policymakers to develop a mitigation strategy for reducing workers’ exposure to microplastics in this business sector.